Genetic Mapping of Modifier Loci in a Mouse Model KCNB1 Encephalopathy

PROJECT SUMMARY
Epilepsy is a common neurological disorder that will affect 1 in 26 Americans during their lifetime. There is
a range of severity, with developmental and epileptic encephalopathies (DEEs) being among the most
severe and medically challenging. DEEs are a heterogenous group of disorders characterized by infant-
onset seizures that respond poorly to available treatments, electroencephalographic (EEG) abnormalities,
developmental delay/intellectual disability, and elevated mortality risk. DEEs are primarily due to monogenic
variants that arise de novo in the affected child. Although each gene-based etiology is rare, collectively the
incidence of DEEs is estimated at 1 in 2,000 live births, representing a significant public health burden. Poor
response to available treatments is a defining feature of DEEs, representing a significant unmet need for
effective therapies. DEEs share overlapping clinical characteristics despite multiple genetic etiologies,
suggesting that disruption of final common pathways underlies these phenotypes. Identifying modifier genes
that broadly influence epilepsy penetrance and expressivity may reveal these shared pathways. Our
previous work showed that modifier genes often modulate function of multiple monogenic DEEs, and these
same genes are also implicated as risk genes in common epilepsies with complex genetic basis. In the
current study, we propose to identify modifier genes using a newly developed mouse model carrying the
human DEE variant KCNB1-p.G379R that was identified as a pathogenic variant associated with
developmental delay/intellectual disability, features of autism spectrum disorder, abnormalities in
background EEG, and multiple seizure types that responded poorly to available treatments. We recently
developed a Kcnb1G379R mouse model that recapitulates core aspects of the clinical phenotype, including
spontaneous recurrent seizures, abnormalities in background EEG, and altered neurobehavior. Phenotype
severity is dependent on strain background, suggesting a contribution of modifier genes. Based on these
observations, we hypothesize that phenotype severity in the Kcnb1G379R DEE model is influenced by genetic
modifiers. We will address our central hypothesis in three subaims. First, we will ascertain seizure and EEG
phenotype severity in Kcnb1G379R mice on a diverse genetic panel using BxD recombinant inbred strains.
Second, we will catalog differences in gene expression between Kcnb1G379R and WT mice on the C57BL/6J
and [C57BL/6J]F1 strains. Third, we will integrate information from subaims 1A and 1B by perforning QTL
mapping and candidate gene analysis to identify modifier loci and putative candiate genes that influence
epilepsy severity. Advancing our understanding of the epilepsy gene network architecture for KCNB1-
associated DEE will promote development of targeted therapeutic interventions and has the potential to
benefit a broad population of individuals with DEE and other epilepsies.

Public health relevance
PROJECT NARRATIVE Developmental and epileptic encephalopathies are particularly severe infant-onset epilepsies that are difficult to treat and pose a significant lifetime burden for patients, families, and society. Varying severity of epilepsy in KCNB1-associated encephalopathy in humans and mouse models suggests a contribution of genetic modifiers. Identifying modifier loci that influence severity of epilepsy will support the development of better treatments to improve the lives of individuals with developmental and epileptic encephalopathy.